Determining Genetic Variants Associated with Rotator Cuff Tearing, Tear Progression and Tendon Repair Healing

Rotator cuff tearing affects over 17 million U.S. people accounting for over 3.8 million physician visits per year
and is the most common shoulder disorder affecting Veteran’s over the age of 40. We have previously shown
that an inherited predisposition contributes to the risk of rotator cuff tearing. We have also identified various
genetic variants associated with the predisposition to rotator cuff tearing including SNPs in ESRRB, SASH1,
SAP30BP, GLCCI1, THSD7A and ZNF804A genes and have confirmed association of variants in TNC variants
with rotator cuff tearing. Finally, we have shown that a family history of rotator cuff tearing as well as the same
genetic variant of the ESRRB gene associated with rotator cuff tearing are associated with failure of rotator cuff
healing after repair. These variants were identified utilizing a genetic database developed using funding from a VA
Merit Review Grant as well as large genetic databases including the UK Biobank and the Kaiser Permanente
Research Bank [KPRB]. There are multiple limitations of the current genetic variant information with
regards to rotator cuff tearing. 1.) There is no information regarding the association of genetic variants and
the severity of rotator cuff injury. 2.) There is limited genetic information regarding rotator cuff variants
associated with requirement for revision repair. 3.) There is no genetic information regarding progression
of rotator cuff tear severity in patients treated nonoperatively. The current proposed study will address all
these limitations which is possible using the unique data within the Million Veteran’s Program (MVP)
datasets.
Non-operative treatment and surgical repair are both reasonable options for the management of rotator cuff
tears. Clinical decision making between the two treatment options partly depends on the risk of tear
enlargement with non-operative treatment versus failure of healing with surgical repair and being able to
effectively identify these tears prior to treatment. Currently no biologic or genetic markers have been identified
to be associated with tear progression and only ESRRB and TNC variants have been identified to associate
with failure of healing. No genetic variants have been identified to associate with tear severity. Identification of
genes or genetic variants predictive of tear severity, tear enlargement as well as failure of surgical repair
requiring revision repair would enhance the clinical decision-making process regarding a recommendation of
early operative or non-operative treatment.
The purpose of this study is to expand the current list of genetic variants associated with rotator cuff tearing,
increasing rotator cuff severity, increasing tear severity with non-operative treatment and rotator cuff repair
failure requiring revision repair. Patients with rotator cuff tears defined by having had a rotator cuff repair will
be identified in the MVP cohort. A GWAS will be performed to identify genetic variants associated with rotator
cuff tearing using MVP cases and controls and a regression analysis will be performed to identify
demographic and tear anatomic factors from MRIs associated with the identified variants. Patients who have
undergone multiple repairs on the same shoulder (revision repair) in the MVP cohort will be identified and
candidate gene analysis will be performed to determine variants associated with the requirement for multiple
repairs. Finally, all patients with sequential MRIs on the same shoulder without preceding or intervening
surgery will be identified in the MVP cohort and evaluated for tear enlargement. Candidate gene analysis will
be performed to determine variants associated with tear enlargement. Polygenic risk calculators will be
created for both tear progression and requirement for revision repair that will translate the data directly to the
clinical care of patients with rotator cuff tears to optimize surgical versus nonsurgical decision making.

Public health relevance
The most common shoulder disorder Veterans are treated for as they age is rotator cuff tearing. Non- operative and surgical repair are both reasonable options for tearing although each has its own associated risks. Nonoperative treatment has risks including tear enlargement which negatively impacts the results of repair success if required. Tear enlargement occurs in up to 50% of tears treated non-operatively. Surgical repair has the primary risk of failure of healing which occurs in an average of 25% of repairs and can lead to revision repair. No biologic markers have been identified to associate with tear enlargement or requirement for revision. We plan to identify genetic variants associated with rotator cuff tearing, tear enlargement and requirement for revision repair using the MVP cohort. Polygenic risk calculators will be created for tear progression and requirement for revision repair. Identification of variants will help optimize the treatment of Veteran’s with rotator cuff tears by biologically defining the risks of non-operative versus surgical treatment.